Integrated Health Sciences Facility Core

Project Summary (IHSFC)
The mission of the Mount Sinai Center on Health and Environment Across the LifeSpan (HEALS) is to
promote team-based environmental health science (EHS) research that embraces a life course approach to
EHS. Within the Center, the Integrated Health Sciences Facility Core (IHSFC), serves as a key linchpin in
the Center's activities, providing researchers with expert consultation on exposure science, toxicology, life
course human development, biomarkers of exposure and biological response, lab feasibility assessment and
access to clinical and epidemiologic population resources. The IHSFC promotes research translation with the
Community Engagement Core(CEC) and connects Center Members with additional Mount Sinai Core
resources, such as those found in our Clinical Translational Science Award (CTSA). This work is facilitated in
part through our very close CTSA relationship, as Dr Rosalind Wright, Center Deputy Director and Phenotyping
and Effect Modifier Facility Core (PEMFC) leader is also the CTSA director. Dr Maida Galvez, our CEC Leader,
also leads Community Engagement in the CTSA giving us substantial access to, and expertise in, clinical and
translational research resources. Working with Center Members we adapt our expertise and resources to fit
measures that are ideal for different life stages with a focus on particular critical periods (pregnancy, infancy,
early childhood, adolescence, midlife, elderly) during which individuals are commonly more susceptible to
environmental exposures. Exposure assessment offerings include targeted and untargeted exposure assays,
tooth based biomarkers that reconstruct early life environment, and satellite based remote sensing “big data”
models that assess air pollution and weather among other variables. The IHSFC also fosters studies that
emphasize environmental justice, as well as environmental clinical research (i.e. the role of environmental
factors on patient response to treatment and/or disease progression). We help Center investigators establish
teams of cross-disciplinary collaborators who together will extend the boundaries of environmental health
sciences. The IHSFC has developed innovative methods to comprehensively measure past exposure to
environment insults and facilitated access to clinical populations and biospecimen archives that have led to
new R01 grants in EHS. The IHSFC does not replicate services provided by other Mount Sinai core labs, such
as those supported by our CTSA. Rather, the IHSFC leverages and supplements CTSA resources to facilitate
Center Member access to additional relevant core labs (e.g. CTSA sequencing core) as well as the Mount
Sinai institutional biobank (BioME). The IHSFC is a resource that allows researchers to build highly efficient
and collaborative teams that conduct research that positively impacts health across the lifespan. In sum, the
IHSFC serves as a gateway to a variety of expertise and resources under a single administrative umbrella,
providing an intellectual milieu that promotes collaboration and brings EHS to research programs across the
Mount Sinai Health System.